CAR T cells targeting mesothelin and secreting bispecific antibodies targeting fibroblasts in pancreatic cancer

PROJECT SUMMARY
CAR T cell therapy for solid tumors is hindered by a lack of tumor-specific antigens that are safe to target and
homogenously expressed throughout the tumor, difficulty infiltrating the tumor due to dense tumor stroma, and
suppression of CAR T cell function by the tumor microenvironment (TME). We plan to address these issues
using novel meso-FAP CAR-TEAM cells that simultaneously target mesothelin, a solid tumor antigen that has
already been proven safe to target in patients, and cancer-associated fibroblasts (CAFs), which inhibit T cell
infiltration and suppress T cell function in the TME. The CAFs are targeted with T cell-engaging antibody
molecules (TEAMs) secreted from the CAR T cells that bind to CD3 and fibroblast activation protein (FAP), which
is highly expressed on CAFs. The TEAM allows for CAF elimination by CAR and non-CAR T cells in the tumor.
We have already demonstrated that meso-FAP CAR-TEAM cells kill pancreatic cancer cells and CAFs in vitro,
in vivo, and in patient-derived ex vivo models and have superior anti-tumor function compared to meso-CAR T
cells alone. For the UG3 phase of this project, we will further optimize meso-FAP CAR-TEAM cells by
determining the best mesothelin binder to use (SS1 vs. a novel binder developed by our lab), optimal route of
injection (IV vs. IP) for targeting pancreatic tumors, and rationale drug combinations that address CAR T cell
limitations in solid tumors. We will improve antigen density using an ADAM17 inhibitor (INCB7839) to prevent
mesothelin cleavage from pancreatic cancer cells, optimize CAR T cell killing and persistence using ibrutinib to
polarize meso-FAP CAR T cells to a Th1/Th17 phenotype, and further prevent suppression by the tumor
microenvironment using a PD1 inhibitor (pembrolizumab). These drugs will be singly combined with meso-FAP
CAR-TEAM cells to determine which best promotes efficacy in our preclinical models. Collectively, these results
will inform the design of a phase I clinical trial for pancreatic cancer patients with advanced disease. During the
UH3 phase, we will determine the safety and tolerability of meso-FAP CAR-TEAM cells. We have chosen
pancreatic cancer as our first solid tumor target due to the dismal prognosis of the disease, the high percentage
of patients with mesothelin-expressing tumors, and the known role of CAFs in promoting tumor growth. While
our primary objective will be to determine safety, we will also monitor patient outcomes (progression and survival)
while performing correlative studies to determine CAR T cell phenotype and function. We will also monitor the
tumor and tumor microenvironment for mechanisms of response or resistance, such as changes in antigen
expression and immunosuppressive cells. Overall, this project will develop a novel CAR-TEAM design to target
a solid tumor and its microenvironment while optimizing the trial design through rigorous preclinical testing. If
successful, the meso-FAP CAR T cell product could be directly applied to other mesothelin-expressing solid
tumors and the knowledge gained from the UG3 phase will inform on the critical aspects of CAR T cell function
to optimize prior to initiating a clinical trial.

Public health relevance
PROJECT NARRATIVE Solid tumors are a mixture of cell types that support tumor growth and prevent the immune system from killing cancer cells. We’ve designed a method to reprogram immune cells to target not only cancer cells but also eliminate support cells. We will optimize this therapy through rigorous preclinical testing and then test it in a clinical trial in patients with pancreatic cancer.